Characterizing BLA dopaminergic and glutamatergic mechanisms of dynamic drug seeking

PROJECT SUMMARY
Relapse and craving in addiction are heavily controlled by environmental cues that evoke dynamic motivational
states and reinforce actions. Both the basolateral amygdala (BLA) and dopamine (DA) signaling are critical for
associative learning processes and cue-driven motivational states. The BLA receives dense dopaminergic
projections and is enriched with D1 DA receptors (D1DRs), however BLA DA functions in addiction remain largely
unexplored. Presentations of cocaine-predictive stimuli increase extracellular DA levels and activate neurons
within the amygdala, while BLA D1DRs influence drug-seeking behaviors and their activation increases
excitability of BLA principal neurons - a major target of DA inputs into the BLA. As there are extensive excitatory
projections from the BLA to the nucleus accumbens (NAc), if BLA DA and D1-neurons are underlying facets of
state dynamics-driven drug seeking behaviors, synaptic strength within this pathway may be uniquely potentiated
following binge-like cocaine seeking. Understanding the role of BLA activity and DA signaling in drug seeking
will reveal novel insight into the brain circuitry that drives emotional learning and addiction-related behaviors to
provide a strong scientific framework for investigating mechanisms underlying affective diseases. This proposal
will make use of new tools to record and manipulate DA and D1 neurons in the amygdala to investigate
their contributions to dynamic cocaine seeking behaviors (Aim 1) and investigate how binge-like cocaine
self-administration impacts the functional connectivity of glutamatergic BLA to NAc circuits (Aim 2).
First, I will measure in vivo DA signaling and D1-neuron activity in the BLA during cocaine self-administration
using fiber photometry to test the hypothesis that BLA DA transmission and D1-neuron activity will track the
emergence of dynamic, sensory-guided drug seeking motivational states. I will also optogenetically inhibit BLA
D1-neurons during the same paradigm to investigate if BLA D1-neurons play a necessary role in state-level
control of binge-like drug seeking. Finally, in an ex vivo preparation, I will use optogenetics to stimulate the
terminals of glutamatergic BLA projection neurons in an NAc slice while recording the resulting local field
potentials after rats undergo cocaine self-administration. These studies will test the hypothesis that BLA-NAc
excitatory synaptic strength will be modulated by the pattern of drug use history via drug state-intermittency
information from the BLA. This proposal will establish fundamental principles by which dopaminergic and
glutamatergic mechanisms interact within the amygdalostriatal system to influence the emergence and control
of dynamic drug-seeking motivational states.

Public health relevance
PROJECT NARRATIVE Environmental cues can reinforce actions and evoke strong, dynamic motivational states during drug seeking and craving to prompt relapse, which poses a significant public health problem in humans with substance use disorders. This proposal will use cutting-edge in vivo and ex vivo techniques to record neural signals and manipulate neuronal activity within the basolateral amygdala, a brain region critical for encoding environmental context information. Understanding how the dopaminergic signaling within and the glutamatergic projections from the basolateral amygdala are engaged during addiction-like behaviors will provide novel insight into mechanisms underlying affective diseases.